Stress response and neural network function in women with vasomotor symptoms

The broad goal of Project 1 of the Brigham/Harvard SCORE Center for Stress and Neural Regulation of
Reproductive Aging Health Outcomes is to advance the health of postmenopausal women by determining stress
responsivity in vasomotor symptoms (VMS) occurrence and persistence and to characterize neural processes
and neurobiological mechanisms linking VMS with stress responsivity. VMS are the most common symptoms
during and after menopause, occurring in up to 85% of women, lasting 7.4–9.0 years on average, and persisting
for 10+ years in 33–40% of postmenopausal women. Investigations of stress mechanisms underlying VMS have
important public health significance due to their high prevalence, impact on quality of life, and adverse health
correlates. VMS disrupt sleep and are associated with cardiometabolic disease, which, together with risks of
hormone therapy used to treat VMS, increase susceptibility to dementia in aging women. We propose a novel
conceptualization of VMS as a chronic stress condition based on our preliminary data and that of others indicating
associations of stress responsivity with VMS. Differences in responsivity to evoked stress tasks in women with
VMS suggest underlying disruptions in stress-related neural networks (e.g., anterior cingulate cortex,
hippocampus, orbitofrontal cortex, insula) and in the inhibitory neurotransmitter gamma-aminobutyric acid
(GABA), which regulates stress networks, as is seen in chronic stress conditions (e.g., anxiety, pain).
Dysregulated stress responses may reflect neural processes through which stress mediates VMS. Project 1 will
innovatively combine the robust methodology of an evoked stress paradigm with state-of-the-art functional
magnetic resonance imaging and magnetic resonance spectroscopy to cross-sectionally investigate acute stress
responsivity, neural network function, and GABA concentrations in women with and without VMS referred by
Project 2 (Project Viva cohort). We will determine longitudinally whether dysregulation of neural stress networks
and GABA predict persistence of VMS over a 2-year follow-up period. In conjunction with the Sleep Resource
Core (SRC), we will examine whether sleep disruption comorbid with VMS further blunts acute stress
responsivity. Similarly, we will test whether perceived stress contributes differentially to stress response
dysregulation in those with VMS. Project 1 is integrated within the Brigham/Harvard SCORE, through enrolling
participants and obtaining relevant longitudinal data from the Project 2 cohort, examining mechanistic neural
stress processes underlying VMS in parallel with Project 3, utilizing sleep metrics obtained by the SRC, and
teaching and mentoring junior faculty and trainees through the Career Enhancement Core. Leveraging these
synergistic SCORE and extensive Brigham/Harvard institutional resources, our study will make major
contributions to the health of aging women by identifying neural stress mechanisms linked to VMS—potentially
pointing to novel treatments for VMS that may also improve sleep and cardiometabolic health, with downstream
implications for dementia susceptibility in aging women.

Public health relevance
NARRATIVE Hot flashes and night sweats, or vasomotor symptoms (VMS), affect up to 85% of postmenopausal women, persist 10 or more years in 33–40% of postmenopausal women, and are strongly liked with stress, which exerts its effects through the brain. Understanding biological mechanisms underlying VMS occurrence and persistence will have significant public health impact because VMS affect so many women, have a negative impact on quality of life, and are associated with sleep disruption and cardiometabolic disease, which increase susceptibility to dementia in aging women. As part of the Brigham/Harvard Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes, this study will advance the health of postmenopausal women by determining stress responses, neural processes, and neurobiological mechanisms that are affected when VMS occur and persist.